Rehabilitation Strategies for Memory Dysfunction After Traumatic Brain Injury

DESCRIPTION (provided by applicant): More than 3.17 million Americans are coping with long-term disabilities due to traumatic brain injury (TBI). Since most TBI research focuses on developing acute treatments to prevent or minimize long-term disabilities, chronic TBI survivors represent a large, underserved population. Chronic TBI survivors could significantly benefit from therapies that promote endogenous synaptic plasticity mechanisms. In both experimental models of TBI and in human TBI, previous studies have found that the hippocampus is highly vulnerable to brain injury. Although often not directly mechanically injured by the head injury, in the weeks to months following TBI, the hippocampus undergoes atrophy and exhibits deficits in long-term potentiation (LTP), a persistent increase in synaptic strength that is considered to underlie learning and memory. The overall objective of this grant proposal is to understand the molecular mechanisms that contribute to hippocampal-dependent LTP deficits and learning impairments in the weeks to months after TBI. Given the critical role of the hippocampus in forming declarative memories, we propose that identifying the molecular mechanisms that underlie the deficits in hippocampal LTP after TBI could provide therapeutic targets to improve hippocampal-dependent learning after TBI. To this end, our laboratory has found that activation of extracellular signal-regulated kinase (ERK) and one of its downstream effectors, the transcription factor cAMP-response element binding protein (CREB), is significantly impaired in the hippocampus from 2 weeks to 3 months after TBI. ERK and CREB are required for long-lasting forms of LTP as well as hippocampal-dependent memory formation. Thus, we hypothesize that a pharmacological treatment which stimulates ERK activation in the hippocampus will improve hippocampal- dependent learning deficits at chronic time points after TBI. Indeed, our preliminary data demonstrate that there are deficits in the activation of ERK in TBI animals after a hippocampal learning task and that this can be rescued with a phosphodiesterase inhibitor. Furthermore, when animals at 3 months after TBI receive a phosphodiesterase inhibitor prior to training, hippocampal-dependent learning deficits are ameliorated when assessed using the Morris water maze task and contextual fear conditioning. In Aim 1, we will identify the underlying molecular mechanisms that contribute to the deficits in ERK and CREB activation in the hippocampal after TBI. In Aim 2, we will test the hypothesis that increasing ERK and CREB activation will rescue hippocampal LTP after TBI. In Aim 3, we will determine if increasing ERK and CREB activation improves hippocampal-dependent learning deficits after TBI. This project is highly supported by an established group of investigators who provide expertise in the molecular mechanisms of hippocampal-dependent LTP, learning and memory, and TBI. The proposed studies will provide new insights into the molecular mechanisms of hippocampal-dependent learning impairments after TBI, and develop therapeutic strategies to improve hippocampal-dependent learning for chronic TBI survivors.

Public health relevance
PUBLIC HEALTH RELEVANCE: Traumatic brain injury (TBI) is a major cause of disability in the United States. There are currently no treatments to improve learning and memory functioning in chronically disabled TBI survivors. This grant will identify the biochemical mechanisms that underlie learning and memory disabilities after TBI and investigate whether an FDA-approved drug can restore learning and memory functioning in the weeks to months after TBI. Traumatic brain injury (TBI) is a major cause of disability in the United States. There are currently no treatments to improve learning and memory functioning in chronically disabled TBI survivors. This grant will identify the biochemical mechanisms that underlie learning and memory disabilities after TBI and investigate whether an FDA-approved drug can restore learning and memory functioning in the weeks to months after TBI. __SpecificAimsTextDelimiter__ There are an estimated 3.17 million people coping with long-term disabilities due to traumatic brain injury (TBI) in the US, resulting in an economic burden exceeding $56.3 billion annually. Studies have consistently shown that cognitive performance is impaired for months to years after the initial TBI, significantly impeding rehabilitation. The hippocampus, a brain area essential for forming memories, is highly vulnerable to TBI. Although the chronic histopathological changes that occur in the hippocampus after TBI are well known, the molecular basis for chronic hippocampal-dependent learning deficits is still unknown. Thus, there are no FDA-approved pharmacological therapies available to improve learning and memory deficits after brain injury. To fill this knowledge gap, we have begun investigating the chronic molecular changes that occur in the injured hippocampus. Using the parasagittal fluid-percussion brain injury (FPI) as a clinically relevant model of TBI, we have found that although several protein kinases critical for memory formation are altered in the hippocampus, these alterations are rapid and transient, and return to non-injured levels within days after the TBI. The central hypothesis of this proposal is that when the chronically injured hippocampus receives stimuli that would normally induce memory formation, the hippocampus is unable to activate protein kinases required for memory formation, thus resulting in chronic learning and memory deficits. We now have novel data supporting this hypothesis. After training on a hippocampal-dependent learning task, activation of extracellular signal-regulated kinase 1/2 (ERK), a protein kinase critical for hippocampal memory formation, is impaired in the hippocampus of TBI animals. Treatment with rolipram, a phosphodiesterase (PDE) inhibitor, to potentiate ERK activation, rescues the deficit in ERK activation after hippocampal learning, and excitingly, improves hippocampal-dependent learning deficits when assessed with the Morris water maze task and contextual fear conditioning. Thus, our findings indicate that rolipram treatment to increase ERK activation is a potential therapeutic avenue to improve chronic learning impairments after TBI. Specific Aim 1: To identify the molecular mechanisms that underlie the deficits in ERK and CREB activation in the injured hippocampus. During hippocampal-dependent learning, ERK is activated and elicits changes in gene expression by activating the transcription factor CREB. However, after brain trauma we have found that activation of both ERK and CREB are decreased in the hippocampus at chronic time points. Our preliminary data suggest that the upstream activators of ERK, mitogen-activated protein kinase kinase 1/2 (MEK1/2), B-Raf, and protein kinase A (PKA), are all misregulated at chronic time points after TBI. In this aim we will use pharmacological manipulation of hippocampal slices and subsequent biochemical analyses to determine if alterations in the PKA/B-Raf/MEK1/2 signaling pathway are the cause for the deficits in ERK and CREB activation after TBI. These experiments are a critical first step to identify the pharmacological targets to rescue ERK and CREB activation deficits after TBI. Specific Aim 2: To determine if chronic deficits in hippocampal long-term potentiation (LTP) after TBI are due to impairments in ERK and CREB activation. Hippocampal LTP is a persistent increase in synaptic strength that is thought to underlie memory formation. At chronic time points after TBI, the expression of LTP lasting greater than 60 min is impaired. There is an intriguing correlation with ERK and CREB inhibitors, which similarly block expression of LTP. In this aim we will utilize hippocampal slice electrophysiology and activate ERK and CREB in hippocampal slices using rolipram, a phosphodiesterase inhibitor, which activates ERK by increasing cAMP levels and PKA activity. We will determine if rolipram rescues the deficits in hippocampal LTP and determine if this rescue is mediated through ERK by co-administration of inhibitors of ERK activation. These experiments will enable us to directly link deficits in ERK and CREB activation to deficits in hippocampal LTP after TBI. Specific Aim 3: To determine if rescue of the deficits in ERK and CREB activation improves hippocampal-dependent learning and memory deficits after TBI. We have found that treatment of TBI animals with rolipram rescues the deficits in ERK activation after learning. In this aim, we will use contextual fear conditioning and a working memory task to determine if rolipram treatment prior to training improves learning and memory deficits at chronic time points after TBI. These experiments have the potential to establish a novel therapy to promote cognitive recovery after TBI. The majority of TBI research is focused on preventing the early devastating consequences of TBI by developing acute neuroprotective strategies. However, the current 3.17 million chronic TBI survivors could benefit greatly from rehabilitative therapies that capitalize on enhancing endogenous synaptic plasticity mechanisms. These proposed studies are innovative in their approach by determining the molecular basis for TBI-induced deficits in hippocampal synaptic plasticity and using this knowledge to develop a rationally-derived strategy to improve learning and memory in the underserved population of chronic TBI survivors.